High Heat and Human Health: The Impacts of Heatwaves on Kidney Disease and Data Driven Solutions (The 4H Proposal)

Project Summary
The last five years have been the hottest on record with urban areas suffering the brunt of
increased temperatures through the urban heat island (UHI) effect. During periods of
heatwaves, the UHI effect further increases local temperatures through and iterative process of
increased energy use and storage, with urban areas commonly being 5-10C warmer than rural
areas. The impact of heatwaves on human health are seen with increased morbidity and
mortality during periods of heatwaves. Furthermore, there is increasing recognition of the
detrimental impact of warming global temperatures on kidney functioning. The goal of this work
is to 1) expand on previous work that established the relationship between heat waves and
hospitalization due to kidney dysfunction by investigating potential environmental moderators
(e.g., impervious land use, decreased green space, and being historically redlined) of this
association; 2) utilize the knowledge to action theory of intervention development to translate
these research findings into preliminary community action; and 3) obtain advanced skills and
expertise in applied environmental health for reducing environmental health disparities due to a
changing climate. This work will set the foundation for a larger, in-depth study aimed at testing
and evaluating interventions to decrease the impacts of heatwaves on human health.
Establishing community partnerships during the knowledge to action aim study will be
paramount for future intervention refinement and evaluation. Future studies will continue to
utilize the knowledge to action framework and principles of community based participatory
research to develop innovative methodologies for decreasing environmental health disparities
and creating health equity.

Public health relevance
Project Narrative Climate change is the largest public health threats in the 21st century, with rising global temperatures particularly harming the kidneys of individuals in high-heat environments. Bridging data science insights on the link between heatwaves and kidney disease hospitalization with community engagement is crucial for preparing communities to effectively respond to escalating temperatures. By employing the knowledge-to-action framework, this work aims to unite data science and community wisdom, laying the foundation for community-level interventions that mitigate morbidity and mortality stemming from heat-induced kidney issues.